Preventing Mental Disorders Among Women Internally Displaced by War in Ukraine: The SHAWL Trial

PROJECT SUMMARY
The war in Ukraine has provoked the world’s current largest humanitarian displacement: since February 2022,
one-third of Ukrainians have been forced to leave their homes, resulting in upwards of 7 million internally
displaced persons. Most of Ukraine’s displaced persons are women, and nearly half of them reported that
mental health is the area of life most impacted by the war. Approximately one in five persons affected by
conflict will develop mental disorders, notably depressive and anxiety disorders. Thus, preventing displaced
women from the burden of mental disease is critical. This is particularly significant as women will have difficulty
accessing evidence-based mental health care in Ukraine, if early symptoms develop into full disorders. We
propose to adapt a community-based Acceptance and Commitment Therapy (ACT) intervention to prevent
mental disorders among women displaced by the war in Ukraine. ACT is an evidence-based intervention that
uses acceptance, mindfulness, and behavior change processes to improve psychological flexibility. Our
transnational, multidisciplinary team of community partners, mental health experts, and behavioral clinical trial
scientists has conducted studies with war-affected populations in Ukraine and successfully used ACT to
improve health behaviors among disadvantaged populations in Eastern Europe. This project is innovative in
the humanitarian context: ACT is only being newly evaluated as a mental health prevention strategy among
displaced populations, has not yet been evaluated as such in Ukraine, and has not been evaluated as a single-
session intervention. However, existing evidence on ACT as a prevention strategy suggests that adapting ACT
for use among women internally displaced by war in Ukraine has strong potential to reduce risks for long-term
adverse mental health effects. Guided by insights and lived experience of community members including
displaced women in Ukraine, we will adapt and implement the intervention with our community partner, the
Alliance for Public Health (“Alliance,” a leading non-governmental organization in Ukraine that serves
vulnerable populations across the country), as well as leading mental health experts in Ukraine. As a direct
result of the war and the needs of displaced populations, the Alliance is serving the health needs of impacted
communities via mobile medical vans. We will evaluate an adapted, single-session ACT group intervention in
Western Ukraine. As part of the services offered through the mobile vans, we will use instruments we
previously validated to screen and enroll women identified as at risk for depressive and anxiety disorders. Our
central hypothesis is that an ACT intervention delivered in a humanitarian context will help displaced women
learn skills to improve psychological flexibility, thereby decreasing symptoms of depression and anxiety and
preventing onset of mental disorders. The expected outcome of this award is a potentially effective, scalable,
and low-intensity intervention that could create capacity beyond this planning grant and prevent at scale the
development of mental disorders among displaced women affected by the humanitarian crisis in Ukraine.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is aimed at informing methods of preventing mental disorders among migratory individuals, specifically through adapting and delivering an Acceptance and Commitment Therapy-based single-session group intervention targeting reductions in depressive and anxiety symptoms among women in Ukraine displaced by the 2022 war. In order to adequately design a subsequent fully-powered study, we will conduct a pilot clinical trial to evaluate the intervention’s potential effectiveness and implementation outcomes. The proposed research is directly relevant to NIMH’s Strategic Plan for Research via its focus on testing innovative approaches to inform mental health prevention and reduce health disparities, including in global settings.